Blood transcriptomics as CT adjuvant to exclude hemorrhage in acute stroke

What? We will test the accuracy of an RNA-seq based biomarker assay to predict the diagnosis of stroke in a
minority population (African American). We will investigate the impact of sex and race on test accuracy, and
investigate novel sequencing approaches to speed up the time to obtain actionable results (Nanopores).
Why? When using the thrombolytic tPA, time is of the essence, as the drug must be administered within 3-4.5
hrs of stroke onset. The sooner with in this time window that tPA can be administered, the greater the benefit.
In addition, intracerebral hemorrhage must have been excluded by CT scanning; currently the sole method to
make this therapeutically critical determination. Delays in radiologist interpretation of CT results, or lack of
available imaging facilities is the most common reason for thrombolytic treatment not being initiated. . Thus
corroborative use of a highly sensitive blood test would permit ER physicians to be confident of their CT
interpretation in settings without onsite CT reading by a radiologist. Timely administration of tPA would thereby
be permitted reducing stroke burden. Accordingly, a rapid biomarker test to exclude hemorrhage in acute
stroke would reduce door to needle times, lower mortality, and improve outcome in stroke.
Stroke burden is higher in African Americans and females, yet these populations have lower representation in
genomic research. We test the impact of sex and race by assessing test accuracy derived from a single sex or
race, and then tested in the opposite sex, or Caucasians. These experiments will determine whether mixed sex
or race derived tests are more accurate than those derived from a single population. Finally, we investigate
approaches to speed up testing using novel Nanopore sequencing technology.
How? Our studies of blood biomarkers, developed at Grady Memorial Hospital Marcus Stroke Center, offers a
diagnostic blood test that discriminates between ischemic and hemorrhagic stroke. We do not rely on single
biomarkers but rather use analysis of the entire transcriptome (all RNA) in venous blood, by the use of next
generation RNA sequencing. These data provide highly accurate stroke diagnosis, determine stroke subtype,
offer powerful prediction of outcome, and show differences and treatment response by sex. We hypothesize
transcriptome differences in peripheral blood can predict CT diagnosis of hemorrhagic vs. ischemic stroke. We
propose to recruit patients from the Grady memorial hospital, and obtain blood samples for RNA sequencing.
From this dataset we will test three specific aims: AIM ONE: Determine the accuracy of blood RNA profiles to
predict CT documented hemorrhagic stroke. AIM TWO: Determine the effect of sex and race on transcriptomic
profile accuracy. AIM THREE: Show the accuracy of rapid RNA measurement techniques to identify ischemic
brain hemorrhage profiles.
IMPACT: A rapid point of care blood test to diagnosis stroke and stroke subtype will increase the percentage of
the acute stroke population eligible for tPA therapy, significantly reducing stroke morbidity and mortality.

Public health relevance
Here we investigate a blood test to identify stroke patients who are eligible for tPA therapy. We use whole blood whole transcriptomic to analyze blood RNA patterns to identify signatures of stroke, and then test the impact of sex and race on this test accuracy. Finally we investigate a novel rapid sequencing approach which has the potential to enable timely point of care transcriptome analysis for stroke diagnosis.